Spatiotemporal dynamics of epileptic activity

PROJECT SUMMARY
Epilepsy is a neurological disorder that is characterized by spontaneous, recurrent seizures. However, a
significant population (~1/3rd) of focal epilepsy patients does not respond to anti-epileptic drugs. Furthermore,
alternative treatment strategies (such as electrical stimulation or resective surgery) depend on accurate
localization of the seizure onset zone, which can be difficult with current technology. This may be due to poor
spatial resolution of clinical recording modalities, such as electroencephalography. To this end, this project
seeks to identify unique markers that arise from activity within the seizure onset zone and thus, elucidate the
mechanisms responsible for seizure recruitment in drug-resistant focal epilepsy. In the long term, the results
generated by this research will not only increase our overall understanding of epilepsy pathology, but also
refine individualized therapies for drug-resistant focal epilepsy patients. The overall hypothesis is that the
spiking activity from the seizure onset zone interacts with the local field potential of the macroscopic penumbra
and that this relationship is unique in human focal epilepsy. To fulfill this objective and test the overall
hypothesis, the following aims will be pursued: (1A) Determine the spatiotemporal spike-triggered average
between spiking activity and the LFP by accounting for both spike timing and location. (1B) A mathematical
model of seizure activity within and outside of the seizure onset zone will be developed to corroborate the
results. (2A) Sort spikes from the ictal epoch into excitatory and inhibitory populations using template-
matching and modeling of convex hull changes. (2B) Investigate the spatiotemporal dynamics of excitatory-
inhibitory populations during a seizure. The results from this analysis will yield a powerful multi-scale
characterization of network states during and around seizure events. The computational approaches that will
be utilized will probe specific mechanisms that underlie seizure onset, propagation, and termination. The
outcomes of this proposal may have translational implications that facilitate identification of the seizure onset
zone or the development of novel therapeutic strategies, such as intracortical stimulation approaches.
This proposed research will be conducted in a collaborative and interdisciplinary environment with significant
training potential as it includes growth in opportunities for mentorship, collaborations, publications,
grantsmanship, and communication. Specifically, this research will be conducted under the mentorship of
experts at the University of Chicago in computational epilepsy work. This training experience will also provide
opportunities to build expertise in scientific inquiry, epilepsy pathology, computational modeling, theoretical
neuroscience, nonlinear dynamics, and data analysis.

Public health relevance
PROJECT NARRATIVE The research proposed in this training plan aims to investigate seizure dynamics by utilizing a combination of modeling efforts and analyses from clinical microelectrode array recordings from adult pharmacoresistant focal epilepsy patients. This research is relevant to public health because understanding seizure mechanisms may facilitate the identification of the seizure onset zone or lead to the development of novel therapeutic strategies for pharmacoresistant focal epilepsy, such as intracortical stimulation. This work will directly support the mission of NIH to seek fundamental scientific knowledge that will specifically help diagnose and treat epilepsy.